NEUROHORMONAL MECHANISMS OF SALT APPETITE

The primary goal of this project is to investigate the cellular and molecular mechanisms through which adrenal steroids mediate their behavioral actions on the control of sodium appetite. Adrenal steroids act upon the brain to arouse sodium appetite and do so by activating the brain angiotensin system as well as by suppressing inhibitory neuropeptide systems such as oxytocin (OT) and the tachykinins (TKs). These effects are mediated by genomic mechanisms involving mineralocorticoid and glucocorticoid receptors that are expressed throughout the brain acting in concert with non-genomic mechanisms. We have uncovered a novel, nongenomic action of adrenal steroids in the amygdala that has focussed our attention on this brain region, as well as upon the GABA-benzodiazepine receptor system. The interrelated Specific Aims are intended to elaborate on the genomic and non-genomic mechanisms of adrenal steroid action in terms of the neuropeptide systems and the GABA-benzodiazepine system and their interactions with each other in the arousal of sodium appetite. The Specific Aims investigate: 1) Genomic control of salt appetite involving mineralocorticoid and glucocorticoid receptors using the antisense technique; 2) Non-genomic control of salt appetite in the amygdala of the rat brain using local application of steroids and benzodiazepine agonists and antagonists; 3) Involvement of genomic control of the expression of key neuropeptides that are either excitatory or inhibitory for salt appetite; 4) Interaction of genomic and non-genomic mechanisms at the level of neuropeptides and GABAa receptors. Specific hypotheses to be tested include the notion that a genomic mechanism involving mineralocorticoid receptors maintains key components of the GABAa and neuropeptide systems in a state where the non-genomic actions can take place. Another hypothesis is that the non-genomic steroid action involves steroid metabolism to products that act directly upon the GABAa receptor to increase its efficacy. This research is relevant to understanding the role of behavioral and neural control of dietary salt intake, which contributes to the establishment and maintenance of hypertension.